Regenerative Strategies Targeting Retinoic Acid Signaling in Giant Axonal Neuropathy

ABSTRACT
The molecular and cellular processes that control axonal degeneration in response to genetic
mutations are poorly understood, hindering the advancement of regenerative strategies to
improve patient outcomes. In the pediatric neurodegenerative disease giant axonal neuropathy
(GAN), axons degenerate due to loss-of-function mutations in the gene KLHL16. Current
understanding is that gigaxonin, the product of KLHL16, facilitates the proteasomal turnover of
cytoskeletal intermediate filament (IF) proteins through its major function as an adaptor between
an E3 ubiquitin ligase and the IF substrate. This mechanism explains the progressive
accumulation of IF proteins in many cell types of GAN patients, but the reasons behind the
selective and profound susceptibility of neurons to KLHL16 mutations are unknown. Seeking to
fill this knowledge gap, we made the novel discovery that retinoic acid (RA) signaling is
dramatically impaired in GAN patient neurons. RA is a critical molecule involved in nervous
system development and regeneration, but its high regenerative potential has not yet been
realized in humans. Our team has a unique opportunity to advance RA biology in the context of
GAN using a focused approach centered on two disease targets we identified: the cellular retinoid
acid binding protein-1 (CRABP1) and the RA receptor β (RARβ). Using a robust and clinically
relevant experimental pipeline of GAN patient iPSC-motor neurons and a new humanized GAN
mouse models that we developed, this project will examine the novel concept that targeted
modulation of RA signaling will enhance axonal regeneration and functional improvement in GAN.

Public health relevance
NARRATIVE Retinoic acid (RA), a derivative of vitamin A, has potent regenerative properties in the nervous system but its therapeutic potential has not been realized due to limitations in selectivity for specific target cells and tissues. We discovered that in the pediatric neurodegenerative disease giant axonal neuropathy (GAN), the actions of RA are restricted by the specific and highly abnormal induction of an RA-binding protein (CRABP1). This project will test if blocking the expression and function of CRABP1 can correct the phenotypes of GAN patient neurons and alleviate disease progression in preclinical models.